Core 2: Outreach & Recruitment Core

SUMMARY / ABSTRACT
The Outreach and Recruitment Core (ORC) of this P50 application will play an integral role in the proposed
research to achieve the overarching goal of maximizing the translational impact of our ethnic disparities research
in our catchment area [Hawai`i and the US-Affiliated Pacific Islands (USAPIs)]. We will perform community
outreach and recruitment activities specifically in support of the three projects and, in the process, engage our
minority populations broadly to increase their awareness of newly identified cancer disparities and obtain their
input on our research and dissemination. The ORC team is highly experienced in community outreach, especially
in engaging local physicians and high-risk minority populations including Asian Americans, Native Hawaiians
and Pacific Islanders (AANHPI) in Hawai`i and USAPI. Also, the P50 and ORC team collectively has a strong
track record of recruiting research participants and administering complex study protocols over the past 30 years.
In Aim 1a, we will establish the P50 SPORE's Community Advisory Board (CAB) to increase public and
healthcare provider awareness of racial/ethnic and geographic cancer disparities among AANHPI in Hawai'i and
elicit community input, participation, and knowledge related to P50 research projects addressing liver, lung and
breast cancers. In Aim 1b, increase awareness of P50 SPORE's newly identified cancer disparities among
healthcare providers and patient community organizations, and engage their input and participation in P50
projects. In Aim 2, to a) conduct the recruitment and data collection for the randomized lifestyle intervention in
Project 1; b) conduct provider and community key-informant interviews, and pilot message testing for Project 2;
c) disseminate the risk assessment research and study findings to stakeholders for Project 3; and d) support the
pilot work funded by the Developmental Research Program (DRP) and Career Enhancement Program (CEP).
Bidirectional engagement with the community throughout the research process is essential for translational
research in minorities to be successful. The ORC, in collaboration with the P50 CAB, will assist current and
future P50-affiliated investigators in obtaining stakeholder and community inputs into their research. The ORC
will build on the extensive experience in community outreach and engagement activities of our Cancer Center,
the only NCI-designated cancer center in the Pacific region, and will establish the foundation for important
translational research addressing cancer disparities in our catchment area and beyond as part of a P50 SPORE.